Particulate Matter-Induced Pulmonary Exosomes and the Lung-Brain Axis

PROJECT SUMMARY AND ABSTRACT
Corporate uranium mines were established in the Southwestern United States from the 1940s-1980s, leaving
behind poorly remediated sites near surrounding residential homes. Inhaled, mine-site derived particulate matter
(PM) has been associated with an increase in serum inflammatory potential and subsequent vascular and
neurological disease. The PM arising from these uranium mines tends to be high in specific toxic, inorganic
metals including vanadium (V), uranium (U), and often nickel (Ni) and arsenic (As). The full scope of systemic
health effects following inhaled mine-site derived PM is unknown, but such inflammatory impacts to the
neurovasculature could promote neurological diseases and the elucidation of such mechanisms has yet to be
discerned. Therefore, the primary objective of this research proposal is to develop a deeper understanding of
the mechanistic, causal basis for mine-site derived PM-induced neurovascular dysfunction. In preliminary
studies, we have observed that mine site PM is more acutely toxic to the lungs and brain compared to regional
background PM. Furthermore, similar studies of inhaled particulates and gases demonstrate a BBB dysfunction
that can drive neuroinflammatory outcomes. Therefore, my specific aims will serve two primary objectives: 1)
mechanistically delineate the contribution of circulating PM-induced exosomes as drivers of cerebrovascular
endothelial barrier dysfunction and neuroinflammation. 2) quantitatively assess endothelial cell dynamics
following treatment with circulating exosomes from PM-exposed mice using high-content, single-cell imaging.
This proposal will serve as a high-risk, high reward project in a supportive academic environment where
investigators can take advantage of several shared resources. We will take full advantage of the outstanding
facilities at the University of New Mexico Health Sciences Center, including the Brain and Behavioral Health
Institute (BBHI) and the Biomedical Research and Integrative Neuroimaging Center (BRaIN), where the MRI, is
housed. Data from these studies will ultimately lead to essential information pertinent to Southwestern
populations in close proximity to abandoned uranium mines, as well as governing agencies involved in air-quality
regulations.

Public health relevance
PROJECT NARRATIVE Poor remediation of abandoned commercial uranium mines throughout the Southwestern United States has subjected Native tribal communities to metal-based (uranium, vanadium, arsenic) environmental exposures. Recent data suggest that inhalation of fugitive mine site derived dust may have neurovascular consequences. The proposed research intends to explore this relationship and evaluate serum-derived exosomes as a potential mechanism driving PM-induced neurovascular endothelial dysfunction.